Pathophysiology and prevention of degeneration of heterograft biomaterials due to advanced glycation end products and serum protein infiltration

Bioprosthetic heart valves (BHV), fabricated from heterograft biomaterials such as glutaraldehyde-fixed bovine
pericardium (BP), are widely used as a replacement for patients who have severe heart valve disease (HVD),
which affects millions of people worldwide. Despite being effective, a limitation of BHV fabricated from BP is
that they undergo structural valve degeneration (SVD) which limits durability. Although most commonly
attributed to calcification, recent research has shown that advanced glycation end products (AGE) and serum
protein infiltration also contributes to SVD. AGE mechanisms impair endothelial cell growth and may
mechanistically contribute to lack of endothelialization of BHV experimentally and clinically. Many studies to
inhibit calcification of BP have been done; however, strategies to mitigate AGE-serum protein accumulation
have just begun to be explored. Through our studies we have recently identified, the AGE-inhibitor
pyridoxamine (PYR), a vitamin B6 vitamer, to be a leading model compound that is effective in significantly
reducing AGE accumulation and serum protein uptake of BP both in vitro and in vivo in rat subdermal implant
studies. Furthermore, we have also established an innovative modification of BP with Poly-2-methyl-2-
oxazoline (POZ), which significantly reduced serum protein uptake both in vitro and in rat subdermal explants.
The central hypothesis of both my dissertation and this proposal is: Pretreatment of BP with PYR and POZ can
mitigate AGE and serum protein pathophysiology that contributes to noncalcific SVD mechanisms. Ethanol
(EtOH) pretreatment of BP, an FDA approved anti-calcification methodology, will be a mechanistically based
experimental intervention in my study design, that will help explore the interactions between calcific and non-
calcific SVD mechanisms. Aim 1: Investigate in vitro the mechanism and efficacy of inhibition of AGE and
serum protein infiltration to enhance heterograft biocompatibility by studying endothelial cell-BP interactions.
Subaim 1a: Evaluate the effects of PYR pretreatment of BP to mitigate AGE and serum protein mechanisms:
blood outgrowth endothelial cell (BOEC) culture studies with high shear flow simulation. Subaim 1b: To
determine the effect of POZ mediated serum protein exclusion on promotion of BOEC adhesion and reduction
of endothelial activation. Aim 2: To investigate the mechanism and efficacy of inhibition of AGE and serum
protein SVD pathology, and interactions with calcification using rat subdermal BP implants: PYR and POZ
studies. Subaim 2a: To study the efficacy of PYR pretreated BP, with or without ethanol pretreatment, on
mitigating AGE-serum protein pathophysiology and calcification using a rat subdermal implant model. Subaim
2b: To study the efficacy of POZ alone, and the combined BP pretreatment with PYR, POZ, and ethanol for
mitigating AGE, serum protein uptake and calcification in the rat subdermal implant model. The findings from
this proposal will advance my research training and contribute to advances in our knowledge of SVD of BHV.

Public health relevance
Project Narrative: Advanced glycation end products and serum protein infiltration is one of the leading mechanisms that cause structural valve degeneration of bioprosthetic heart valves. The proposed research aims to further elucidate the basis of this mechanism by examining the effects of pretreating bioprosthetic heart valve leaflet material with two model compounds: pyridoxamine, an AGE-inhibitor, and Poly-2-methyl-2-oxazoline, which we have shown to significantly reduce protein infiltration. This work will provide insight into novel strategies to potentially mitigate AGE and serum protein infiltration and enhance biocompatibility, thus circumventing a leading mechanism of SVD that has not been investigated before.